Structural Biology of Complex Enzymes

Project Summary
Natural product biosynthesis encompasses a wealth of interesting chemical transformations. The
corresponding enzymes have tremendous biocatalytic potential within or outside their natural pathways.
Realizing this potential requires a structure-based understanding of enzyme function as well as substrate
selectivity and range. Three enzyme systems will be investigated in this project. Thioesterases (TEs)
form the macrolactone scaffolds of macrolide antibiotics by cyclizing linear polyketides during offloading
from carrier proteins. The TEs are potential biocatalysts to diversify the macrolide repertoire in the
ongoing battle against antibiotic resistance. However, TEs generally cyclize only their native substrates
and offload linear products for non-native substrates. How several TEs direct macrocycle formation will
be determined by visualizing covalent intermediates trapped by an unnatural amino acid substituted for
the TE catalytic nucleophile. The structures together with assay data from a panel of substrates and
products will provide a wealth of information on the determinants of macrocycle vs. linear product
formation and will inform efforts to engineer macrocycle diversity. The second enzyme is a putative
terminal amidation domain (TAD) that forms linear amide products during offloading from carrier proteins
in several nonribosomal peptide synthetase (NRPS) pathways. ORFs encoding TADs are widely
distributed in the bacterial kingdom, located predominantly at the end of NRPS gene clusters. Building
on the results developed during the current funding period – a comprehensive database of TAD
sequences, biochemical data and crystal structures – we will test the hypotheses that TAD catalyzes
amidation and that nitrogen is derived by oxidative release or amide hydrolysis. Identification of the
unknown nitrogen source could enhance the potential of TADs as general amidation catalysts. The third
enzyme system is the BURP cyclases that form burpitides, a new class of ribosomally synthesized and
posttranslationally modified peptide (RiPP) natural products in plants. The recently discovered Cu- and
O2-dependent BURP cyclases use a novel Cu center to form crosslinks in short core peptides prior to
proteolytic release of the mature burpitides. Building on our initial crystal structure, this project will
enhance the understanding of BURP function and structure. We will expand the structure database of
BURP cyclases, visualize a fully formed Cu center, see how substrates engage with the BURP cyclase
active site, investigate possibilities for substrate alteration by mutagenesis, and learn how proteases
release cyclized burpitides and not their linear precursors. Each of the three enzyme systems has
potential for several applications that will be advanced by the results of this project.

Public health relevance
Project Narrative Microbes and plants make many fascinating chemical compounds, highly interesting “natural products” that are the basis of many drugs. Thus, nature’s biosynthetic machinery is a potential target for engineering to develop new drugs or improve existing ones. These studies will discover the 3D structures and fundamental details about how enzymes catalyze some highly unusual chemical reactions, thereby aiding drug discovery efforts and advancing fundamental enzymology.